Influence of Eccentric Exercise on Muscle and Joint Health After ACL Injury

PROJECT SUMMARY
The purpose of this K01 Mentored Research Scientist Development Award is to promote Dr. Lindsey Lepley’s
independent research program by training under Dr. David Goldhamer and other skilled musculoskeletal
physiologists, orthopaedic surgeons, statisticians and engineers at the University of Connecticut, to gain the
necessary scientific skills and career development to advance her research line to a new level. Dr. Lepley’s
long-term career goal is to lead a research team focused on developing evidence-based strategies to prevent
the development of post-traumatic osteoarthritis (PTOA). The training provided by this K01 would provide her
with the needed support to become a productive independent scientist who is able to measure the
inflammatory, neural, and morphological responses of muscle and alterations in bone and cartilage health to
traumatic joint injury and subsequent rehabilitation strategies. The central tenant of this K01 is to identify
rehabilitation strategies capable of promoting muscle and joint health after anterior cruciate ligament (ACL)
injury. To date, concentric exercise is the standard mode of exercise prescription after ACL injury. Yet, multiple
systematic reviews have shown that concentric exercise does not restore muscle strength and does not deter
the onset of PTOA. Emerging evidence suggests that mechanical stress achieved via eccentric exercise is
required to initiate strain-sensing molecules that promote the recovery of muscle. We have recently
demonstrated that embedding eccentric exercise into a rehabilitation program early after ACL reconstruction
promotes the recovery of quadriceps strength better than concentric exercise. Though promising, eccentric
exercise is often avoided clinically, as the notion that eccentric exercise is associated with muscle injury has
been perpetuated in the literature, and the underlying benefits of eccentrics to muscle remain undefined.
Further, the ability of eccentric exercise to prevent the development of PTOA in a high-risk population has
never been studied. To provide the evidence-based data needed to support the incorporation of eccentric
exercise into rehabilitation, we will establish a non-invasive, clinically-translatable, ACL injury in a rat model
and describe the time course of biomechanical alterations, inflammatory response and PTOA progression (aim
1). We will then use this model to report the effectiveness of eccentric exercise to treat muscle weakness (aim
2) and promote bone and cartilage health after ACL injury (aim 3). The central hypothesis is that eccentric
exercise will attenuate deficits in neural activity and alterations in muscle morphology, thereby restoring
quadriceps strength and promoting joint health more effectively than the current standard of care of concentric
exercise after ACL injury. The rationale for conducting this in vivo research, which establishes the physiological
benefits of this rehabilitation strategy, is to ultimately inform the development of future clinical trials and
generate essential new skills that will promote Dr. Lepley’s independent research program.

Public health relevance
PROJECT NARRATIVE Post-traumatic osteoarthritis (PTOA) is a major cause of lifetime disability, for which no cure currently exists. PTOA is especially problematic following anterior cruciate ligament (ACL) injury, where regardless of treatment, PTOA affects over 50% of ACL injured limbs. Using a rodent model that closely resembles human ACL injury, the proposed studies will elucidate whether eccentric exercise is more effective than concentric exercise at promoting muscle and joint health after ACL injury for the purpose of providing clinicians with evidence-based treatment options for the nearly 300,000 Americans who experience ACL injury each year.